Cancer Research Training and Education Coordination

PROJECT SUMMARY: CANCER RESEARCH TRAINING AND EDUCATION COORDINATION (CRTEC)
As the only NCI-designated cancer center in South Florida, Sylvester Comprehensive Cancer Center
(Sylvester) is deeply committed to providing cancer-focused education, training, and career enhancement to
trainees and faculty. Guided by Kerry L. Burnstein, PhD (TB), Associate Director (AD) Education and Training,
other Sylvester leaders, Sylvester’s External Advisory Board and the Cancer Education Leadership Council,
Sylvester’s CRTEC continues to fulfill the broad mission of building and sustaining a robust pipeline of
exceptional, collaborative, and interdisciplinary cancer researchers and healthcare professionals from diverse
backgrounds. CRTEC aims are to 1) provide cancer research career enhancement across the continuum of
students, trainees, faculty, and non-faculty healthcare professionals, through stage-specific scientific and
professional development programs; and 2) coordinate center-wide training and educational programs that
facilitate collaborative and interdisciplinary basic, clinical, translational, and population-based cancer research.
In alignment with Sylvester’s Strategic Plan, Burnstein and the ADs Community Outreach and Engagement
(COE) and Diversity, Equity, and Inclusion (DEI) partner to enhance the successful participation of women and
underrepresented minority populations in cancer research careers. Working with Sylvester’s Office of Outreach
and Engagement (SOOE), CRTEC helps ensure that an understanding of cancer disparities and diversity
within Sylvester’s catchment area and corresponding priorities informs trainee and faculty cancer research.
CRTEC has developed and maintains a database of more than 4,000 current and former trainees for outcome
tracking, activity planning, and evaluation of CRTEC programs. Sylvester continues to invest $1.3M annually in
education and training, which includes funding for additional positions on cancer research-focused training and
career development grants. This support has led to an increase in cancer-relevant, peer-reviewed funding
(annual direct costs) from $1.2M to $4.1M during the reporting period. This includes an increase in K awards
from five to 12, and F awards from seven to 25, as well as several new cancer-focused training grants. Guided
by CRTEC, Sylvester faculty have renewed key training and career development grants and obtained new
grants, including an NCI R25 to support undergraduate cancer research and career development, and an NCI
T32 in cancer equity for post-doctoral associates. Investments in education and training as well as extensive
recruitment of scientists and clinicians have increased Sylvester’s capacity to train and mentor a diverse
pipeline of individuals and provide them with a uniquely rich environment for learning, mentoring, and pursuing
cancer research careers.